LINCS Data Coordination and Integration Center

DESCRIPTION (provided by applicant): The goal of our LINCS Data Coordination and Integration Center (DCIC) is to lower barriers to LINCS. We propose to support a compute infrastructure that makes it possible to aggregate and analyze all perturbational data (LINCS and non-LINCS) in a cost effective and scalable manner. In addition we will make those analytical capabilities accessible to a broad range of users from disparate scientific backgrounds including bench biologists, big data scientists, and software developers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The LINCS program is putting into motion a large-scale effort to generate perturbational profiles of representing a breadth of cell types, perturbagen and read-outs of cellular state. The challenge now is to maximize the impact of that data generation investment by catalyzing the research community's interaction with the data, if this is successful, the biomedical impact will be enormous. For the computational community, democratizing access to LINCS data will allow unprecedented engagement in biomedical research. For basic biologists, LINCS data analysis will provide a new lens with which to understand molecular function and cellular processes. And for drug developers and clinical investigators, the LINCS lens represents a powerful new approach to comprehensively understanding not only the effects of therapeutics against intended targets, but also their toxicity-inducing off-target effects. If sch LINCS approaches become routine, this would represent a fundamentally new paradigm for biology research and therapeutic development.